Einstein-Mount Sinai Diabetes Research Center

This proposal seeks to continue the development of the regional Einstein-Mount Sinai Diabetes Research
Center (ES-DRC) to support the discovery, application and translation of scientific knowledge for the treatment
and cure of diabetes. Building upon our highly collaborative and successful transdisciplinary interactions
among Einstein and Mount Sinai and other regional investigators, the ES-DRC will serve as a New York
regional nexus to i) enhance diabetes research, education and training; ii) attract, mentor and retain research
investigators; iii) provide state-of-the-art Biomedical Research Core services to maximize research productivity;
iv) foster collaborations locally and regionally, and v) promote the translation of scientific findings from the
bench to the bedside. To accomplish these goals, we have reorganized the ES-DRC with five cutting-edge
cores spanning the basic, pre-clinical, and clinical research ‘translational’ divide: 1) Animal Physiology Core; 2)
Stable Isotope & Metabolomics Core; 3) Human Islet & Adenovirus Core; 4) Immuno-Technology Core; and 5)
Translational Research Core. These Biomedical Research Cores support our larger and collaborative research
base across multiple institutions. For studies directed at the molecular, cellular, tissue, animal based integrated
physiology levels we provide the infrastructure to investigate the basic mechanisms of type 1 and type 2
diabetes. We have also organized a framework by which basic and animal model pre-clinical studies can be
translated into human-based clinical investigation.
To attain these goals, the Administrative Core manages integration and promotion of research and training
among Einstein, Mount Sinai and other affiliated institutional faculty. The Administrative Core also provides
support for our highly successful Pilot & Feasibility Study Program and coordination with the Einstein and
Mount Sinai Clinical Translational Science Awards (CTSA). This infrastructure has also allowed us to maintain
a strong Enrichment program, promote diabetes research and advocacy, and support our philanthropic efforts,
all pivotal for our ongoing faculty recruitment efforts, and management and development of new initiatives. The
five Biomedical Cores provide robust cutting-edge experimental and data interpretative services directly in-line
with the specific support needs of our highly successful, productive and extramurally funded research base.
The Pilot & Feasibility Program continues to draw new young investigators that develop into exceptional
independent senior research investigators. The ES-DRC has created and maintains a robust academic
environment for our recruitment of new and established investigators into diabetes and metabolism research.
Lastly, the cross-institutional support and regional coordination of diabetes efforts are a direct result of the ES-
DRC leadership teams.

Public health relevance
Diabetes and related metabolic disorders are rapidly increasing and have major impacts on both the quality of life and the lifespan of the US population, and are therefore responsible for a large portion of our health care cost burden. The goals of the Einstein-Mount Sinai Diabetes Research Center are to provide resources for molecular, cellular, tissue, organismal, pre-clinical, clinical and translational research to improve our understanding of development of diabetes and its prevention, treatment and eventual cure.